Mitochondrial fission in diabetes-related arrhythmia

PROJECT SUMMARY
Type 2 diabetes mellitus (t2DM) predisposes patients to debilitating cardiovascular disorders, including acute
ischemia/reperfusion (I/R) events and chronic myocardial infarction (MI), both of which promote sudden cardiac
death. Many of the pathophysiological complications of t2DM can be linked to hyperglycemia-mediated
mitochondrial ROS overproduction that is secondary to mitochondrial division (fission). Of importance to
mitochondrial fission is the dynamin related protein 1 (DRP1), a member of the conserved dynamin GTPase
superfamily. The functional importance of DRP1 is underscored by the fact that its over-expression promotes
mitochondrial membrane potential depolarization and cell death whereas its silencing or chemical inhibition
attenuates these processes. The implications of altered DRP1 and mitochondrial fission for modulating
myocardial function and arrhythmias in t2DM remain unknown and will be examined in the context of acute I/R
injury and chronic MI. The activity of DRP1 is regulated by several kinases and phosphatases including the AMP-
related kinase (AMPK), a master metabolic sensor that is central in the pathophysiology of t2DM. By controlling
the balance between ATP generating and consuming processes, AMPK also regulates mitochondrial function in
the settings of I/R Injury and diabetic cardiomyopathy. The overall premise of this project is based on the following
lines of evidence: 1) DRP1 controls mitochondrial division in various cell types, including myocytes; 2) Decreased
mitochondrial fission protects against reactive oxygen species (ROS)-induced mitochondrial depolarization,
mPTP opening, and apoptosis; 3) DRP1-related mitochondrial fission is required for hyperglycemia-mediated
ROS overproduction in various cell types; 4) Acute ROS overproduction in I/R promotes electrical dysfunction
and arrhythmia by destabilizing the mitochondrial membrane potential through the regenerative process of
mitochondrial ROS-induced ROS-release; 5) Chronic ROS overproduction promotes adverse structural and
mechanical remodeling; and 6) In diabetes, AMPK activation inhibits mitochondrial fission by altering DRP1
phosphorylation at specific serine residues in endothelial cells. The central tenant of this proposal is that
mitochondrial fission and its regulation by an AMPK-DRP1 axis plays a central role in t2DM-related cardiac
dysfunction and arrhythmia. In Aim 1, we will determine the role of DRP1-mediated mitochondrial fission and its
regulation by AMPK in the susceptibility of the diabetic heart to acute ROS-related reperfusion arrhythmias. In
Aim 2, we will determine the extent to which impairment in the AMPK-DRP1 axis contributes to post-MI structural
and electro-mechanical remodeling and arrhythmia susceptibility in the diabetic heart. In Aim 3, we will test the
therapeutic efficacy of targeting DRP1-mediated mitochondrial fission in reversing post-MI cardiac dysfunction
and arrhythmia propensity in the diabetic heart. Completion of these studies will yield new mechanistic insights
into the role and regulation of mitochondrial fission in t2DM, and uncover novel mitochondria-targeted therapeutic
approaches for this major public health epidemic.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes mellitus (t2DM) predisposes patients to acute & chronic ischemic insults that promote arrhythmias. Central to myocardial dysfunction in t2DM are fundamental changes in mitochondrial dynamics (fission) that cause oxidative stress. In this application, we will explore the role of mitochondrial fission and its dysregulation by an energy sensing pathway in the susceptibility of the diabetic heart to arrhythmogenesis and we will also test the therapeutic efficacy of targeting this pathway in reversing t2DM-related arrhythmia.